Role of E-cadherin in epithelial barrier dysfunction and fibrosis in idiopathic subglottic stenosis

Dr. Alexander Hillel is a faculty member in the Department of Otolaryngology-Head & Neck
Surgery at the Johns Hopkins School of Medicine where his clinical practice is dedicated to the
medical and surgical management of subglottic stenosis. Through the support of a R01
Research Project Grant, he and co-Investigator, Dr. Ramana Sidhaye, seek to better
understand how the dysfunctional epithelial barrier contributes to the spontaneous fibrosis seen
in idiopathic subglottic stenosis (iSGS). iSGS is a rare but life-threatening disease that
exclusively affects healthy, peri-menopausal women. In iSGS, scar forms in the upper airways
narrowing the subglottic larynx, and resulting in shortness of breath and communication
disability. Specifically, the investigator team will focus on E-cadherin, an apico-adherens
junction protein in epithelium, as the cause for barrier dysfunction in iSGS. The deficiency in E-
cadherin creates a permeable barrier allowing for common antigens to pass through the
epithelium and trigger fibrosis. This proposal will study how the loss of E-cadherin in epithelial
cells leads to scar formation in a mouse model and by using human epithelial cells and
fibroblasts isolated from iSGS patient biospecimens. It will also study a novel surgical procedure
that restores the epithelium after excising scar tissue to assess if E-cadherin is the critical
protein involved in preventing scar from reforming. Finally, the proposal will investigate
improving saccharide binding to E-cadherin, through a process called fucosylation, as a novel
therapy to restore E-cadherin and epithelial barrier function. Through a combination of in vitro
and in vivo modeling, participation from patients with iSGS, and assessment of a novel surgical
procedure, the investigator team is uniquely poised to transform our understanding and
treatment of iSGS.

Public health relevance
Project Narrative Idiopathic subglottic stenosis is a rare but life-threatening disease of the upper airways characterized by scar tissue narrowing the subglottic larynx, and resulting in shortness of breath and communication disability. This proposal will investigate how a deficiency in the epithelial barrier protein, E-cadherin, causes epithelial barrier dysfunction and contributes to the development of the scar tissue that forms spontaneously in the subglottis. The proposal will study a novel surgical procedure that restores the epithelium after excising scar tissue to assess if the E-cadherin is the critical protein involved in preventing scar from reforming.